MINORITY INITIATIVE--TEACHERS AND HIGH SCHOOL STUDENTS

Qualified Central Kentucky students enrolled in high school during the academic year of application serve as apprentices to investigators on biomedical research projects during an eight-week summer program at the University of Kentucky Chandler Medical Center. Research projects are matched to student interest. Students are paid an hourly wage for full- time employment. Minority science teachers or teachers of significant numbers of minority students participate in the teacher component of the same program to receive hands-on research experience to carry back to the classroom. This program is part of a broad-based precollege and undergraduate science outreach effort at the University of Kentucky. Program participants are nurtured by this environment.